Exploring the Parameter Space of High Frequency Magnetic Perturbation in Manipulating Neural Excitability and Plasticity.

Project Summary/Abstract
At Magnetic Tides we developed a radically new NIBS approach, one in which subthreshold modulation of neural
excitability is brought about via oscillating magnetic fields at kilohertz frequencies. This system, referred to kTMP
(kilohertz Transcranial Magnetic Perturbation) significantly increases the range of subthreshold E-field induction,
and through modulation of the envelope of the kHz carrier frequency, can impose E-fields at physiological
relevant frequencies. In the parent grant, the initial experiments are conceived to test tolerability and efficacy of
kTMP in healthy participants, leading to behavioral experiments which focus on improving motor skills with kTMP.
The goal of the supplement research projects are focused on training the supplementee Ms. Ahmad-Ali (trainee
level: pre-doctoral) in a bioengineering project focused on create a setup that enables detailed measurements
of performance during a motor task involving fine and gross movements (Aim1); in parallel, the supplementee
will help the leadership team to perform an engineering gap analysis to clearly document the technological
characteristics of kTMP by establish a Formal Design History File (Aim 2).
The supplementee intends to pursue a career path focused on regulation of biomedical device development. At
this stage in her career her main goal is to gain hands-on experience in a company that is setting the stage to
launch a medical device to the market. By the time her appointment ends, the candidate will gain extensive
experience in technology development and, additionally, she will acquire in-depth understanding of the regulatory
paperwork required to sell a medical device.

Public health relevance
Project Narrative We have recently developed a new non-invasive brain stimulation (NIBS) system, kilohertz transcranial magnetic perturbation (kTMP), that opens a new experimental space for safely modulating neural excitability in targeted areas of the human brain. This project will focus on building and testing an instrumented glove designed to capture detailed motor performance during a reach-to-grasp task. In addition, the supplementee will carrying out an engineering gap analysis to create a Formal Design History File for kTMP that is necessary to prepare a Premarket Submission to the FDA.